Neuroscience Resident Research Program

ABSTRACT
This is a renewal proposal describing the Research Training Program for Neurology and Neurosurgery
Residents at Massachusetts General Hospital (MGH) and Brigham and Women's Hospital (BWH) of Harvard
Medical School (HMS). The program combines the exciting variety of collaborative research opportunities
available at these campuses with a dedicated core group of neuroscience mentors aligned in a two tiered
system which includes a `research' mentor directly responsible for the scientific activities of the candidate and
a `gateway' mentor responsible for the overall career development of the R25 candidate. Research mentors
are selected from the enormous field of researchers at our two institutions and other institutions in the Boston
area. The gateway mentors are selected on the basis of research activity, experience guiding clinicians in the
early stages of successful research careers, and commitment to this program to develop neurology and
neurosurgery residents into effective physician-scientists. In addition, a steering committee closely oversees all
aspects of the resident research training experience. This program has already had tremendous success in its
first 9 years of funding which has included 50 trainees who have produced numerous high-impact first author
publications and earned foundation as well as K12, K23 and K08 funding and been hired into faculty positions.
This programmatic structure builds on these successes to ensure that neurology and neurosurgical residents
obtain the highest level of training possible to launch careers as outstanding physician-scientists.

Public health relevance
NARRATIVE There is a widely recognized need for translational and clinical research in neurological diseases which can only be met by continuing to train new investigators who will bring innovative solutions to neurological health problems. This application looks to renew a successful program linking the tremendous depth and breadth of research resources available in the Harvard University system to a small group of dedicated senior neuroscientists mentors for the career development of residents.